Identifying Osteoporosis Genes by Whole Genome Sequencing and Functional Validation in Zebra Fish

Project Summary/Abstract
Osteoporosis has become a major and growing worldwide public health burden. Due to fears of side effects,
the use of osteoporosis drugs has fallen by as much as 50%. Thus, there is an unmet need to develop new
drugs for osteoporosis; or to develop personalized therapeutic approaches with the ability to takes into account
individual variability for each patient. Using human genetic studies to identify new druggable targets should
overcome the current treatment crisis in osteoporosis. Although GWAS have been successful in discovering
associated genetic variants with complex traits, more than 88% of GWAS loci are non-coding, which makes the
identification of causal variants and their targeted genes a difficult challenge; thus, limits the use of human
genetics information in drug discovery. To overcome these challenges and get better understanding of GWAS
findings, we proposed to utilize whole genome sequencing in large well-phenotyped populations as well as the
CRISPR/Cas9 gene-editing zebrafish model to identify potential causal variants and targeted genes influencing
skeletal integrity. Our findings may eventually lead to new diagnostics and therapeutics of osteoporosis. We
proposed three specific aims, including: 1) Fine-map previous BMD GWAS loci by existing WGS in 10,000
individuals from the Trans-Omics for Precision Medicine (TOPMed) Program to identify potential causal
sequence variants (functional variants) that are responsible for GWAS signals; 2) Identify novel structural
variation and novel rare sequence variants associated with BMD by performing a whole genome scan using
the same 10,000 WGS samples. We will replicate findings in an additional 5,000 samples selected from the
GENOMOS/GEFOS consortium; 3) Functionally characterize up to 30 genes selected from aims 1 and 2 in
knockout zebrafish by CRISPR/Cas9 gene-editing systems. State-of-the-art technologies for rapid phenotyping
in zebrafish will be applied to a broad range of physiologies (skeletal development, ontogenesis, and
regeneration) and characteristics (bone mass accrual, morphology, and mineral density). Our proposal is
fundamentally important and represents the logical next step in skeletal genetics research. The results will lead
to much needed new drug development to overcome the growing treatment gap in osteoporosis.

Public health relevance
Project Narrative (Relevance) This research is relevant to public health because osteoporosis and subsequent osteoporotic fractures affects more than 34 millions of US older adults, yet its biological etiology are not fully understood. The proposed project will identify potential causal-variants and their targeted genes via fine-mapping on previously reported GWAS loci of osteoporosis; identifying novel rare variants and structural variations associated with osteoporosis via whole genome sequencing on 10,000 samples; as well as characterizing their biological function by CRISPR/Cas9 gene-editing zebrafish models. We will also cross-reference our findings with pharmaceutical databases to identify potential targets for osteoporosis and osteoporotic fractures therapy.